Comparative effectiveness of food prescription programs for food insecure families with young children

In the U.S., 17.3% of families with children report food insecurity with even higher rates among lower-income families. Given the impacts of food insecurity on diet and health, a growing trend of “Food is Medicine” seeks to address health disparities through the integration of food and nutrition security initiatives into healthcare systems. The Food is Medicine (FIM) framework prioritizes nutrition security—access to high quality foods that promote well-being—to address health and healthcare-related outcomes across different populations. Expanding access to FIM interventions to address health disparities was a major focus of the 2022 White House Conference on Hunger, Nutrition, and Health. Subsequently, several states have begun using Medicaid funding for FIM interventions, including food prescription programs (i.e., medically tailored groceries, produce prescriptions). Food prescriptions have the potential to manage and prevent diet-related health conditions, reduce healthcare utilization, and reduce food insecurity, however, poor usage threatens their effectiveness with prescription redemption rates as low as 9-18% in the literature. There is a need for rigorous research on usage and acceptability of food prescription interventions as a tool to reach the youngest populations at risk for food and nutrition insecurity. While food prescriptions may originate with a healthcare provider and be paid for by health insurance, the execution of these programs lies with community-based organizations and food retailers. This proposal addresses the urgent need for community organizations to understand how to increase utilization of food prescription programs among families with small children. This research employs a community-engaged approach to develop and test two innovative food prescription interventions among 225 Medicaid families with children (ages 2-6) who have screened positive for food insecurity at local pediatric clinics. This population has been chosen to match eligibility for a recently started Medicaid food prescription program in our state (New York). Each family will be randomized to one of three study arms and provided a food prescription, focusing on fresh produce, weekly for 26 weeks. The usual care control arm will receive a mobile market-based produce prescription, and the two intervention arms will receive either a customizable box of fresh produce or a choice of meal kits (produce box with recipes and all the complementary ingredients to make 3 healthy meals with the produce), both delivered to their home. We will work directly with community partners who normally deliver FIM programs so that findings can be immediately applicable to FIM practitioners. Outcomes will focus on program utilization (enrollment, redemption, and food usage) for Aim 1 and fruit and vegetable consumption, diet quality, food and nutrition security and cooking self-efficacy for Aim 2. Aim 3 will qualitatively examine program implementation, secondary program impacts, and cost effectiveness. Together these aims will help understand how to address low utilization rates of food prescription programs with the goal of reducing food insecurity among families with young children.

Public health relevance
Project Narrative Food is Medicine interventions are designed to prevent and manage chronic conditions through access to nutritious foods and support services to improve diet quality, food behaviors, and knowledge around food and health. Food is Medicine interventions, including food prescription programs, have been found to help prevent and manage disease in adults, but rigorous evaluation of these interventions in pediatric populations is limited and little is known on how to best increase program uptake across age groups. This research will help understand the attributes of food prescription programs that increase program utilization, fruit and vegetable consumption, and food and nutrition security among low-income families with young children who are at risk for food insecurity.